MANAGEMENT CORE

The Center will be comprised of four functional units: The Management Core, The Data Management/Statistical Core, The Dissemination Core and The Research Programs at each of the three participating Universities. Dr. Sara Czaja will continue to serve as the leader of the Management Core and the Director of the Center. The Management Core will provide leadership for the Center and oversight and direction for all of the Center's activities. Specifically, the Management Core will assume primary responsibility for facilitating the collaboration between the three sites, the links between the Center and the External Scientific Advisory Board and NIH and the links between the Center and the community, relevant government agencies and business/industry. The Management Core will also provide technical support for the research projects and will assist with participant recruitment, and administration of the common core battery of measures. In addition, the core will play a pivotal role in fostering and supporting cross-site Iresearch collaborations and expanding the research program of the Center. The Management Core will also assume primary responsibility for the administration and management of the student pilot research program will serve as the compositor for the "CREATE CV" and all media activities. Finally, the Management Core will integrate and support the activities of the Data Management and Dissemination Cores. The Management Core will build on existing structures for these activities developed for CREATE I and collaborative relationships that are already in place.